Ownership of medical practices, use of intensive care service, and neonatal outcomes

ABSTRACT
Compared to nations of similar economic status, the United States has a high rate of preterm birth and 12-15%
of all newborns require admission to the neonatal intensive care unit (NICU). Both the outcomes and use of
NICU care for all infants varies widely across hospitals and geographic regions, which contributes to inefficient
care delivery and adverse health outcomes for all infants. One significant change in the delivery of perinatal
care has been the rise of private equity, or investor-owned, ownership of both neonatal physician groups
delivering care and hospitals that supply the NICU. In the United States, private-equity corporations are now
estimated to own 25% of all hospitals, and in many specialties such as dermatology, obstetrics, and
ophthalmology these groups have an increasing share of practices nationally. While studies have shown
mixed impacts on adult outcomes, only one small study of private equity ownership in neonatology, the
acquisition of 36 physician groups over an 8-year period, found higher payments to these groups without any
change in outcomes. There have been no further studies of the role of private equity ownership on neonatal
care. This study, then, is designed to examine how ownership of neonatal physician groups, hospitals that
provide neonatal care, or the combination of both affect the outcomes and use of NICU care for newborn
patients in the United States. To study this question, we will link data on private equity ownership of physician
and hospital groups that we have complied to a unique population-based dataset of all births in 15 states over
a 25-year time period that encompass over 40% of all births in the United States. Using a staggered difference-
in-differences approach and previously validated methods we have used to identify private equity acquisitions,
we will examine the following specific aims: (1) Determine the impact of private-equity ownership of physician
groups, hospitals that provide neonatal care, or the combination of both on mortality, morbidity, and length of
stay of infants born prematurely during the birth hospitalization; (2) Determine the impact of private-equity
ownership of physician groups, hospitals that provide neonatal care, or the combination of both on the use of
NICU care, length of stay, and morbidity of term infants with less severe indications for which admission to the
NICU may be discretionary, such as hyperbilirubinemia requiring phototherapy and hypoglycemia; and (3)
understand how changes in ownership differentially affect infants with public insurance compared to private
insurance. At the end of this project, we will have assembled evidence for potential positive, or negative,
effects of private equity acquisition of neonatal care services for stakeholders, and further understand the
potential multiplicative effects of such acquisition of physician and hospitals for patients and their families.

Public health relevance
Project Narrative Over the past 20 years, one significant change in the delivery of perinatal care has been the rise of private equity, or investor-owned, ownership of both neonatal physician groups delivering care and hospitals that supply the NICU. This study will examine how ownership of neonatal physician groups, hospitals that provide neonatal care, or the combination of both affect the outcomes and use of NICU care for newborn patients in the United States. This project is submitted to the National Institute of Child Health and Development (NICHD) with review under the Organization and Delivery of Health Services (ODHS) study section in response to PA- 20-185 NIH Research Project Grant (Parent R01 Clinical Trial Not Allowed).